Liquid Biopsy in Glioblastoma Treated with Chemoradiation and an Oxygen Therapeutic

HYPOTHESIS AND SPECIFIC AIMS
Outcomes for patients with Glioblastoma (GBM), the most aggressive malignant brain tumor in adults, are driven
by the genetic underpinning of the tumor, such as methylation status of methyl guanine methyltransferase
(MGMT) gene promoter and expression of tumor hypoxia genes. Standard treatment for GBM patients is surgery
followed by chemoradiation with routine serial MRI to assess treatment response. After chemoradiation, MR
imaging may exhibit increased enhancement that could represent tumor in 30% or more of cases, the
phenomenon of pseudoprogression (PsP) from treatment. It is challenging to distinguish between true
progression and PsP, so patients and providers need other means to evaluate the disease trajectory. Liquid
biopsy is a non-invasive approach to evaluate disease trajectory through tumor genotype and gene expression.
GBM is a hypoxic tumor; tumor hypoxia is known to curtail response to chemoradiation. Dodecafluoropentane
emulsion (DDFPe) was tested in a Phase IIa trial in association with chemoradiation to treat GBM. DDFPe was
well tolerated, showed reversal of tumor hypoxia, and demonstrated improved progression free survival (PFS)
and overall survival (OS). Enrollment is underway in a Phase IIb trial testing DDFPe as an oxygen therapeutic
(radiosensitizer) in association with chemoradiation treatment in GBM patients. Prior work with DDFPe shows
that PsP, in comparison to true progression, on MR imaging is more prevalent after chemoradiation. The
hypotheses to be tested in this revised Direct to Phase II SBIR application are as follows: 1) Treatment with
DDFPe will alter expression of biomarkers associated with tumor hypoxia and 2) Blood-based biomarkers will
enable differentiation of PsP from progressive disease (PD). Thus, our Specific Aims are directed to explore
this pivotal observation which is to correlate blood-based biomarkers for hypoxia with radiosensitizer treatment
and PsP. FYR Diagnostics will partner with NuvOx to establish liquid biopsy assays that support DDFPe
therapeutic product development. FYR will employ a multi-omics approach to discover novel biomarkers utilizing
enabling technology to enrich extracellular vesicle (EV) subpopulations in patient blood plasma. Circulating EV
biomarkers will aid in identification of patients who may benefit most from radiosensitizer treatment and facilitate
monitoring of response to treatment with or without a radiosensitizer. FYR and NuvOx will work synergistically
to discover and validate hypoxia biomarkers to create an accompanying companion diagnostic assay to aid in
safe and effective use of DDFPe. PsP biomarker development will have massive implications in patient
management in the presence or absence of radiosensitizer treatment, ultimately necessitating creation of LDT
or IVD assays.
This is the first time that liquid biopsies will be studied in GBM in association with a radiosensitizer. We expect
to garner valuable insights into gene expression in chemoradiation treatment, signatures to distinguish PsP from
PD, and predictive patterns with respect to OS.

Public health relevance
PROJECT NARRATIVE The goal for this revised Direct to Phase II proposal is to perform liquid biopsies in glioblastoma patients treated with chemoradiation and a novel oxygen therapeutic, NanO2, in order to develop predictive biomarkers. The application is attached to an ongoing Phase IIb clinical study of NanO2. Testing of biomarkers for hypoxia and tumor DNA will not only provide a way to predict tumor hypoxia, but will also help to elucidate a path to differentiation between pseudo-progression and true progression.